Administrative Core

Project Summary – Administrative Core A
The Administrative Core is designed to provide scientific leadership, effective communication, and an
administrative support structure to ensure the coordination of all PDX Development and Trial Center (PDTC)
activities. The essential services provided by the Core include: administrative support for all of the investigators
in each project and core; scientific oversight and progress review for each project; coordination of selection
processes for Pilot Studies and integration of these investigators and their projects into the PDXNet program
as they evolve; fiscal and financial management and oversight for all components of the PDTC; and
organization and communication of all PDTC meetings and activities. The Administrative Core is also
responsible for all interactions with the NCI staff, both scientific and administrative.
The overall objectives of the Administrative Core are to:
1. Establish and maintain an administrative structure to provide support for and management of all PDTC
activities.
2. Foster an environment to maximize collaborative and translational research among PDTC investigators
between Wistar, MD Anderson, and Penn and between other PDTC/PDXNet and NCI initiatives.
3. Ensure compliance with all institutional, governmental, and NCI regulations and policies.